Role of Aldehyde Dehydrogenase 2 in Resolution of Fibroproliferative ARDS

PROJECT SUMMARY/ABSTRACT
This proposal presents a revised 2-year research plan focused on improving the understanding of pathologic
pulmonary fibrogenesis following acute lung injury and ARDS. The candidate is currently an Assistant Professor
of Medicine at the University of Colorado in the Division of Pulmonary Sciences and Critical Care Medicine. The
outlined proposal builds on data generated during the candidate’s current NIH/NHLBI K08 award to explore new
mechanisms in the pathogenesis and resolution of Fibroproliferative ARDS (FP-ARDS). Data generated from
the proposed research strategy will position the candidate for submission of an independent R01 proposal.
The acute respiratory distress syndrome (ARDS) is a major healthcare problem in the US. Many ARDS survivors
experience more severe disease and impaired long-term outcomes due to the development of pathologic
pulmonary fibroproliferation. This excessive fibroproliferation, termed Fibroproliferative ARDS, is characterized
by early, over-exuberant fibroproliferative responses with accumulation of myofibroblasts and deposition of
extracellular matrix components, due in part to increases in TGF-β. This is followed by a late phase typified by
persistent fibrotic changes. There remains a critical need to understand the drivers of FP-ARDS, and to develop
therapeutics that attenuate, or reverse, the fibrotic sequelae of ARDS.
Oxidant injury and the production of toxic, reactive aldehyde compounds, is key to the pathogenesis of lung
injury and fibrogenesis. ALDH2 is a mitochondrial NADP-dependent enzyme that is best known for its role in
ethanol metabolism, but is also essential for the detoxification of highly reactive lipid aldehydes. This proposal
will evaluate the role of ALDH2 in the pathogenesis of FP-ARDS and test the hypothesis that activation of
ALDH2 will promote lung repair and reduce fibroproliferative sequelae of lung injury. The candidate will
address two research Aims. Specific Aim 1 will focus on the mechanisms by which ALDH2 inhibits fibrogenesis
in lung parenchymal cell (fibroblast and epithelial cell) cultures models. Using genetic (siRNA) inhibition of
ALDH2, and specific enzyme activators, we will measure levels of oxidant injury, lipid peroxidation products, and
enzyme activity. We will evaluate key steps in the pathogenesis of pulmonary fibrosis, including TGF--
dependent signaling and gene expression in fibroblasts, and senescence phenotypes in epithelial cells. Specific
Aim 2 will utilize mice with a genetic deletion of Aldh2 (Aldh2-/-) to determine if absence of this enzyme results in
enhanced severity or duration of fibroproliferation in a validated pre-clinical model of FP-ARDS (bleomycin). A
pharmacologic activator of ALDH2 will be used in a human Precision Cut Lung Slice model to determine if
enhanced enzyme activity can attenuate fibroproliferation, or accelerate resolution and repair.
The proposed project will define a novel mechanism in the pathogenesis of fibroproliferative ARDS and explore
potential therapeutic targets that could lead to improved pharmacologic interventions for patients at risk for
developing FP-ARDS.

Public health relevance
PROJECT NARRATIVE The Acute Respiratory Distress Syndrome (ARDS) represents a major healthcare problem in the United States, and many ARDS survivors experience long term consequences as a result of persistent, excessive fibroproliferation, termed Fibroproliferative ARDS (FP-ARDS). Further developing our understanding of the pathogenesis, clinical relevance, and relationship of FP-ARDS to long-term outcomes may aid in the development of novel interventions for a large subset of patients with ARDS. This application addresses the role of the antioxidant enzyme ALDH2 in the pathogenesis of FP-ARDS and in the processes that contribute to repair and resolution of lung injury.